DIRAS3 disrupts K-RAS clustering and signaling, enhancing autophagy and response to autophagy inhibition

Mutant KRAS drives human cancers from several sites, including pancreatic ductal adenocarcinoma (PDAC)
and low-grade serous ovarian cancer (LGSOC). Despite the prevalence of RAS mutations in different cancers,
effective RAS-targeted treatment remains a challenge. KRAS monomers form homodimers and nanoclusters in
the cell membrane to optimize signaling and to transform cells efficiently. Dimerization of KRAS is required for
RAS-driven transformation and cancer growth. Agents that disrupt mutant RAS dimers and clusters can block
oncogenic activity. Recent evidence indicates that inhibition of RAS signaling induces autophagy and enhances
the response to anti-autophagic therapy. Despite four decades of effort, development of effective strategies for
the treatment for mutant KRAS-driven cancers remains a work in progress. Our laboratory has discovered a
novel endogenous physiological RAS inhibitor designated DIRAS3, a 26 KDa GTPase sharing 50-60% homology
with classical RAS family members, but with a distinctive 34 amino acid N-terminal extension that reverses RAS
function. Like RAS, DIRAS3 is prenylated at the C-terminal CAAX site, binds GTP with high affinity, exhibits
weak GTPase activity, and requires membrane association for its biological function. DIRAS3 is downregulated
in a number of cancers including PDAC and LGSOC, and re-expression of DIRAS3 blocks cancer cell
proliferation, inhibits motility, and, importantly, induces autophagy by multiple mechanisms. Recently we have
found that DIRAS3 and a DIRAS3-derived stapled peptide from its α5 domain interact directly with mutant KRAS,
reducing KRAS dimerization and nanoclustering, and inhibiting KRAS signaling. Both intact DIRAS3 and
DIRAS3-derived stapled peptide induce autophagy and potentiate the pro-apoptotic activity of autophagy
inhibitors in PDAC and LGSOC cells. In this proposal, we will study the effect of DIRAS3 on KRAS-dependent
cell growth, migration and effector signaling in MEF cells and genetically engineered mouse model with mutant
KRAS, as well as in KRAS-driven PDAC and LGSOC, better defining the mechanism by which DIRAS3 inhibits
KRAS (Aim 1). We will investigate the mechanisms by which DIRAS3 induces autophagy in KRAS-driven PDAC
and LGSOC (Aim 2). Finally, we will test the ability of DIRAS3 or a DIRAS3-derived stapled peptide in
combination with autophagy inhibitors (CQ/DC661) to enhance apoptosis and growth inhibition in PDAC and
LGSOC (Aim3). These studies will not only lay the groundwork for exploring new therapeutic strategies targeting
KRAS-mutant cancers, but also contribute to a fundamental understanding of the mechanisms by which DIRAS3,
as a tumor suppressor, inhibits mutant KRAS activity and induces autophagy.

Public health relevance
KRAS drives transformation and growth of human cancers from several sites, including pancreatic ductal adenocarcinoma (PDAC) and low-grade serous ovarian cancer (LGSOC), but therapy targeting KRAS remains a work in progress. Upon completion of this grant, we will better understand the role for DIRAS3, a tumor suppressor, in targeting KRAS, inducing autophagy and potentiating the pro-apoptotic activity of autophagy inhibitors in PDAC and LGSOC, opening a new approach to treating KRAS mutant cancers by inhibiting KRAS dimerization/nanoclustering, increasing autophagy and enhancing sensitivity to autophagy inhibitors.